Center on Aging and Population Sciences

The Center on Aging and Population Sciences (CAPS) at The University of Texas at Austin (UT) seeks to renew P30 Demography and Economics of Aging Center infrastructure support to continue successful programs and launch new initiatives to support population-based research on aging. CAPS’s mission is to galvanize research that illuminates how biosocial, relational, institutional, and socioeconomic forces intersect and cascade across the life course, contributing to disparities in health and aging. CAPS will advance this mission across three research themes: (1) Biosocial Processes, (2) Family and Social Engagement, and (3) Socioeconomic and Institutional Contexts. Five specific aims motivate the Center’s work: (1) foster groundbreaking population-based research on developmental processes that shape the pace and quality of aging from birth to death, (2) promote a national community of interdisciplinary population scientists who study aging, including outreach to increase the number and scope of researchers in the field, (3) cultivate and nurture the professional development of the next generation of scholars conducting population-based research on aging, (4) share data and research findings to benefit scientific, policy, and public audiences, and (5) provide the administrative infrastructure to advance the Center’s scientific mission. CAPS will support scientists from multiple academic disciplines through four Cores: An Administrative and Research Support Core, a Program Development and Pilot Core, a Communication and Dissemination Core, and an External Network Core on Aging SGM Populations. Continued P30 support will build on CAPS’s tremendous success. Since its launch as a new P30 Center in 2020, CAPS nearly doubled its number of affiliated faculty and expanded the number of active NIA awards to faculty by 76 percent with a 934 percent increase in funding (from $3.5M to $36.2M). The activities, visibility, and collaborative opportunities provided by P30 infrastructure funding will support CAPS faculty affiliates and expand the reach of the Center across U.S. institutions to advance the field’s understanding of the underlying biological, social, psychological, socioeconomic, and institutional contexts and processes that shape risk and resilience in aging populations.

Public health relevance
The Center on Aging and Population Sciences at The University of Texas at Austin will conduct research to advance public health understanding of the biosocial, relational, institutional, and socioeconomic processes that shape risk and resilience in aging populations. This research will offer new insights critical to furthering the health and well-being of an aging U.S. population.